The University of Southern California and Buck Institute Nathan Shock Center

ABSTRACT- USC-Buck Institute Nathan Shock Center Overall
The biology of aging field is at an inflection point; driven by 30 years of discoveries that have revealed
mechanisms of aging and lifespan determination. Until recently, these studies were deemed
phenomenological, but geroscientists are now transforming the way we approach the study of chronic diseases
and the practice of medicine itself. For this transformation to be sustainable, the basic biology of aging field
must expand. Critical for this expansion, is the training of the next generation of geoscientists. Here we present
an innovative program of activities, with a strong emphasis on training, designed to overcome these
challenges. This includes many Research Sabbaticals, a pilot project scheme and a voucher funding
mechanism to open outside investigators to an unmatched technology platform for aging research.

Public health relevance
NARRATIVE The translation of basic research on aging into preventions and therapies requires a deeper understanding of why aging causes disease. The USC/Buck Nathan Shock Center will fund innovative pilot projects, give access to leading edge technologies focused on aging and mentor junior investigators from across the nation to train them to become the next leaders in the field.